COMPASSIONATE USE PROTOCOL FOR THE USE OF AMD3100 TO MOBILIZE PERIPHERAL BLOO

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this industry sponsored, compassionate use protocol is to determine if AMD3100, added to a G-CSF mobilization regimen, can increase the circulating levels of PB stem cells to be collected by apheresis and transplanted.